Training of Arthritis Research Scientists

ABSTRACT
Rheumatic and autoimmune diseases remain poorly understood, are difficult to manage and treat, and often
result in significant morbidity and mortality. This status quo can only be changed by focusing on research
efforts that build upon and advance the knowledge that has been generated, re-evaluating current dogmas,
and taking advantage of an interdisciplinary collaborative approach to effectively understand these complex
multi-system diseases. Unparalleled scientific expansion in genomics, epigenomics, and systems biology has
fundamentally enhanced our understanding of human biology, and generated a wealth of data and a unique
opportunity to comprehensively investigate the mechanisms underlying human autoimmune diseases. Further,
advances in clinical sciences have created outstanding research opportunities to improve patient outcomes.
The goal of this Training Grant is to prepare the next generation of researchers to become independent
investigators, and lead future efforts to improve care of patients affected by rheumatic and autoimmune
diseases. This will be accomplished by selecting the most promising postdoctoral trainee candidates, and
providing them with the knowledge and skills for a proposed training period of at least 2 years to prepare them
for independence. Our Training Program will include 4 physician-scientists or scientists each year and will
prepare them through a carefully designed individualized didactic experience, with structured mentoring
focused on both scientific and career growth. In addition, our program will prepare trainees for independence
through training in scientific writing, grantsmanship, and leadership skills. This Training Program will be
directed by Dr. Amr Sawalha, with Drs. David Fox and Dinesh Khanna as Associate Directors. Together, this
Training Grant leadership, supported by an external advisory committee which includes 4 scientific leaders with
extensive productivity and mentoring experience, provides a complementary set of expertise to ensure a
successful mentoring program focused on basic, translational, and clinical research. The Training Program
fosters interdisciplinary research, which is evident by a roster of experienced Program Faculty mentors
spanning 15 different units. It is supported by a rich and diverse scientific environment to study autoimmunity at
the University of Michigan, including two NIH-funded Autoimmunity Centers of Excellence (ACE) programs – a
Basic ACE and a Clinical ACE – attesting to our strength in both basic and clinical research. Our Training
Program will focus on six major scientific themes: genomics, epigenomics, and bioinformatics; systemic lupus
erythematosus; inflammatory arthritis; systemic sclerosis; fibromyalgia and chronic pain; and health care policy
and outcome research. There is a significant need for researchers in rheumatic and autoimmune diseases, and
a pressing need for making sure that future independent researchers are well trained and equipped to lead the
effort to understand the complexity of these diseases, identify novel therapeutic options, and improve patient
outcomes. Indeed, our proposed Training Program comprehensively addresses these needs.

Public health relevance
PROJECT NARRATIVE Rheumatic autoimmune diseases are associated with significant mortality and morbidity, and remain poorly understood resulting in a lack of effective and safe treatments. There is a challenging shortage of trained researchers to tackle the complexity of these diseases. The goal of this application is to provide comprehensive training for future independent researchers who will lead the efforts to better understand the mechanisms underlying human rheumatic autoimmune diseases, and improve patient care and outcomes.